TASK 16: Production of Botulinum Complex

This contract provides for process development and related development of biopharmaceutical products under the NIAID Preclinical Services for the Development of Biopharmaceutical Products Program.